Develop a technology for whole-genome sequencing of RNA-DNA triplexes

PROJECT SUMMARY: Yu Liu, PhD (Principal Investigator; PI)
LncRNAs are >200nt RNA molecules that do not translate into protein products. The number of lncRNAs is far
greater than their protein-coding counterparts, but the functions and underlying mechanisms of lncRNAs are less
understood. A few lncRNAs modulate the expression of their target genes through forming an RNA-DNA triple
helix at gene regulatory regions such as enhancers and promoters; this new layer of gene regulation is particularly
important for developmental gene expression programs. However, knowledge about this new regulatory
mechanism is scarce. The research community mainly relies on candidate lncRNA-based methods, not unbiased
whole-genome approaches. The major technological challenge is that we cannot reliably capture whole-genome
RNA-DNA triplexes in vivo.
We propose to capture RNA-DNA triplex by using the differential affinity of Thiazole Orange (TO) to complex
helical structures vs. canonical structures. TO is a classic fluorochrome for double-stranded DNA (dsDNA), but
its affinity to triplex and quadruplex structures of DNA is substantially higher. Because RNA-DNA triplex is
structurally comparable to, but more stable than DNA triplex, we predict that we can use TO to identify genomic
RNA-DNA triplexes. The core of this new technology, TO-Triplex-Seq, comprises Biotin-conjugated-TO
labelling and subsequent Avidin-pulldown, followed by DNA purification and sequencing. We will distinguish
RNA-DNA triplex from other complex helical structures using special RNAse treatments in parallel chromatin
samples. The unique strength of this new technology is that we will specifically capture RNA-DNA triplexes, not
other complexes in which RNA and DNA form a duplex (R-loop) or indirectly interact through other binding
partners.
We will prove the concept and validate this new technology with two specific aims. SA1 will determine the
affinity between TO and synthetic RNA-DNA triplexes and test the framework of pulling-out RNA-DNA
triplexes from a pool containing RNA-DNA triplexes, DNA-only triplexes and dsDNAs. SA2 will establish and
validate the new technology using a multi-scale approach. We will (1) characterize the sequence features of the
RNA-DNA triplex sites; (2) study how triplex formation changes during active and suppressed rRNA biogenesis
which is regulated by a pRNA-rDNA triplex; (3) study whether distinct sets of lncRNAs contribute to triplex
formation in undifferentiated and differentiated hESCs; (4) further annotate the RNA-DNA triplex datasets to
publicly available chromatin state datasets. At the conclusion of this project, we expect to publish a detailed
protocol which others can easily adopt and further build upon. Ultimately, we plan to develop a TO-labeling-
based multiomics toolset that comprehensively describes the RNA, DNA, and even protein components (if
present) of RNA-DNA triplexes and hence contributing to the understanding of transacting lncRNAs.

Public health relevance
NARRATIVE: Yu Liu, PhD (Principal Investigator; PI) We propose to capture RNA-DNA triplex by using the differential affinity of Thiazole Orange (TO) to complex helical structures vs. canonical structures. To validate this new technology, we will apply it to two cellular processes, rRNA biogenesis and human embryonic stem cell differentiation, in which the role of RNA-DNA triplex has been well documented. Successful completion of this project will prove the concept that TO can be used to specifically mark and isolate whole-genome RNA-DNA triplexes.